Role of glutamine metabolism in Dendritic Cell Development

Project Summary
Conventional dendritic cells (CDC) play a central role in protective immunity by connecting innate and adaptive
immune responses. CDCs can distinguish `self' from `non-self' (example pathogen) or `altered-self' (example
cancer) through specialized pattern recognition receptors and help orchestrate the appropriate adaptive immune
response. CDC1 and CDC2 are the two major subsets of CDCs with CDC1s having the unique capacity to cross-
present antigens that is critical for immunity against viruses and cancer. Circulating precursors of CDCs (Pre-
CDCs) infiltrate tissue where they differentiate into CDC1 and CDC2. The relative distribution of these CDC
subsets differ between tissue types and under pathological conditions, suggesting a role of tissue
microenvironment in Pre-CDC differentiation. What factors in the tissue microenvironment might regulate this
process, however, remains poorly understood. Our preliminary studies show that CDC1 differentiation is
regulated by local availability of the amino acid glutamine through its metabolic conversion into glutamate.
Glutamine uptake and utilization increases significantly in rapidly proliferating cells or during catabolic stress,
potentially creating a glutamine deficient local microenvironment. Hence, we hypothesize that metabolic
adaptations in tissue alters local CDC1 differentiation by modulating glutamine levels. In this proposal, we seek
to understand which steps of CDC1 differentiation is regulated by glutamate and its underlying molecular
mechanism. We will focus on epigenetic regulation of gene expression and oxidative stress as potential
pathways by which glutamate mediates this effect. Findings from the proposed work can potentially open new
lines of research linking tissue metabolic adaptations to its immune microenvironment.

Public health relevance
Project Narrative Conventional dendritic cells (CDC) play a central role in immunity including protective responses against pathogens and cancer, autoimmune diseases, outcome of organ transplantation, and response to vaccines. To support their many roles, CDCs have specialized subsets in tissue but mechanisms controlling their tissue distribution are poorly understood. Our work will uncover a novel pathway by which metabolic changes in tissue regulate local distribution of CDC subsets.